Metalloprotein Mechanisms of Redox Regulation and Catalysis

Abstract for Metalloprotein Mechanisms of Redox Regulation and Catalysis
This proposal covers the three R01 grants funding my laboratory and aims to fill gaps in understanding the
mechanisms of crucial aspects of redox regulation and catalysis by metalloproteins from microbes to humans.
Successful completion of this work will reveal novel mechanisms with broad significance to human health, the
environment, and biotechnology. Our research integrates a wide variety of biological, biophysical, biochemical
and computational approaches. In Project Area 1, we will extend recent discoveries of novel bioinorganic and
enzymatic mechanisms of anaerobic microbial CO and CO2 fixation in the Wood-Ljungdahl pathway (WLP),
proposed to have fueled the origin of live on earth. We will reveal the mechanisms of these ancient enzymes:
their generation and use of CO as a substrate, formation of bioorganometallic catalytic intermediates, utilization
of nucleophilic and paramagnetic metal centers as catalysts, requirement of large domain movements and an
interprotein CO channel and recently identified alcove for CO binding and CO2 fixation. We will define how
these unique features choreograph redox activation, substrate and partner protein binding, leading to biological
transformation that chemists are trying to mimic to more rapidly and efficiently accomplish chemically
challenging reactions, e.g., to sequester, activate and convert CO2, methane and syngas into industrially
important chemical feedstocks and fuels. While I started my career studying the WLP, I have applied the same
expertise to other important evolving problems of metabolic regulation in humans by CO and metals and of
mercury toxicity. In Project Area 2, we propose to deliver important discoveries on how human metabolism,
metal homeostasis and the circadian clock are regulated by heme regulatory motifs (HRMs), signaling
molecules (CO and NO), and cellular heme levels and redox poise. Focusing on heme oxygenase-2 (HO2), we
will explore crucial conformational changes between the core and tail of HO2 and how these movements
control protein turnover, protein-protein interactions, and heme conversion to CO, biliverdin and Fe. We will
explore the hypothesis that HO2 serves a dual function in the cell in controlling heme trafficking and turnover.
We will monitor the dynamics and interactions of full length HO2 with its redox partner cytochrome P450
reductase and with its heme donor GAPDH and define mechanisms that regulate heme-controlled HO2
turnover. Following up on our finding that the nuclear receptor Rev-Erbb uses a novel mechanism of redox-
chemical coupling to serve as a CO/NO sensor, we will address how redox and gas binding affect its structure,
function, activity and its interactions with partners like NCoR1 and its heme chaperone. In Project Area 3,
recent successes in purifying and crystallizing the active HgcAB complex and defining its unusual thiolate-
coordinated B12 cofactor, enable our proposed studies of the mechanism of microbial mercury methylation. We
will determine the HgcAB structure, the redox and ligation states of the metal centers during catalysis, and
whether a methyl radical or anion is used by these B12 and iron-sulfur clusters during catalysis.

Public health relevance
Project Narrative: This proposal will fill gaps in understanding crucial aspects of redox regulation and catalysis by metalloproteins from microbes to humans. Our work will integrate a wide variety of biological, biophysical, biochemical and computational approaches to reveal novel mechanisms with broad significance to human health, the environment, and biotechnology.